Monoclonal antibodies against surface epitopes of Treponema pallidum outer membrane proteins

ABSTRACT-Project 3: Immunology
Syphilis is a sexually transmitted infection caused by Treponema pallidum that remains a significant public
health threat. Despite effective testing and treatment algorithms, the rate of syphilis infections is increasing in
the US, especially among economically disadvantaged persons. Development of a vaccine will speed
elimination of this disease and reduce the burden of syphilis complications including congenital disease. This
overall goal of this program is to develop syphilis vaccine candidates, and this project is designed to
characterize the immunological factors associated with protection. This project will isolate, characterize, and
test monoclonal antibodies against syphilis derived from clinical samples obtained by our collaborators as well
as antibodies that are developed in vitro using phage display techniques. The outcome of this work will be a
new set of vaccine candidates that can be advanced to clinical trials.